EARLY UNDIFFERENTIATED CONNECTIVE TISSUE DISEASE

The purpose of this study is to evaluate and follow patients with various rheumatic diseases in order to 1) determine what features are predictive of the eventual disease process over a five and ten period, and 2) generate a hypotheses for future studies. Participants in this study were hospitalized on the Clinical Research Unit for comprehensive evaluation of their disease five times over a ten year period: 1) upon entry into the study; 2) after one year; 3) after three years; 4) after five years; and 5) after ten years. As this is an ongoing long-term observational study, follow-up data continues to be analyzed to characterize early undifferentiated connective tissue disease and its evolution to the more well defined connective tissue diseases such as SLE and systemic sclerosis.